T-bet and Tumor Immunity

DESCRIPTION (provided by applicant): Mouse models of intestinal cancer have been instrumental in understanding oncogenesis and most recently have shed light on the role of innate immunity and the commensal microbiota in colon cancer. Under the aegis of this grant, we recently described a new model of commensal-dependent ulcerative colitis termed T-bet-/- RAG2-/- Ulcerative Colitis (TRUC) that results from T-bet deficiency in the innate immune system. T-bet is a T- box family transcription factor that controls chemokine and cytokine production, regulates host-commensal homeostasis in the colon, and is expressed only in immune cells. Increased levels of T-bet in human colorectal tumors correlate with increased patient survival. TRUC mice develop a severe and highly penetrant colitis driven in part by loss of TNFα regulation in the colon that can be reversed by antibiotics, TNFα blockers, transfer of T regulatory cells or dendritic cell depletion. We have discovered that the majority of TRUC mice spontaneously progress to colonic dysplasia and colorectal adenocarcinoma (CRC) that is dependent on intestinal inflammation. TRUC-associated CRC resembles the human disease, and as a novel pre-clinical model, provides ample opportunity to probe how the inflammatory milieu drives the development of CRC and to test preventative and therapeutic strategies. More work needs to be done, however, to establish the similarity of TRUC colitis associated CRC to the human disease. TRUC colitis and CRC are, in contrast to most other mouse colitis models, independent of Myd88 signaling giving us the opportunity to identify non- Myd88 driven pathways and mediators that may intersect with known Myd88 instigated pathways. Despite a complex inflammatory environment rich in cytokines, growth factors, proteases, inflammatory mediators and significant DNA damage, restoration of T-bet selectively in dendritic cells (DCs) was sufficient to reduce colonic inflammation and prevent the development of neoplasia. The mechanism by which T-bet is activated in DCs to initiate colitis, however, and the generalizability of T-bet function in DCs to other models of inflammatory colitis and CRC is unknown. The overarching theme of this proposal is to understand how T-bet and TRUC associated genetic modifier genes control the development of inflammation associated cancer and to harness that function therapeutically. We propose to 1. Explore the similarity of TRUC caCRC to the human disease and test its therapeutic response to cytokine blockade at various stages of dysplasia; 2. Explore how T-bet in dendritic cells controls inflammation driven CRC.; and 3. Identify genetic modifier genes associated with TRUC. PUBLIC HEALTH RELEVANCE: We recently described a new model of commensal-dependent ulcerative colitis (TRUC) that results from deficiency of the transcription factor T-bet in the innate immune system, and have now discovered that the majority of TRUC mice spontaneously progress to colonic dysplasia and rectal adenocarcinoma that is dependent on intestinal inflammation. TRUC-associated colorectal cancer resembles the human disease, and as a novel pre-clinical model, provides ample opportunity to probe how the inflammatory milieu drives the development of colorectal cancer and to test preventative and therapeutic strategies.

Public health relevance
Project Narrative We recently described a new model of commensal-dependent ulcerative colitis (TRUC) that results from deficiency of the transcription factor T-bet in the innate immune system, and have now discovered that the majority of TRUC mice spontaneously progress to colonic dysplasia and rectal adenocarcinoma that is dependent on intestinal inflammation. TRUC-associated colorectal cancer resembles the human disease, and as a novel pre-clinical model, provides ample opportunity to probe how the inflammatory milieu drives the development of colorectal cancer and to test preventative and therapeutic strategies.